The interplay between nutrient availability and secondary bile acid metabolism in commensal Clostridia mediates colonization resistance against C. difficile

Project Summary/Abstract
In the Theriot laboratory we apply cutting-edge technology and high-throughput methods to analyze the gut
microbiome and metabolome using a range of experimental techniques and animal models.
We leverage many
approaches that span diverse fields including bacterial genetics, bacterial physiology, protein engineering,
biochemistry, and apply a variety of omic approaches (microbiomics, transcriptomics, proteomics, and
metabolomics) in vitro and in vivo to define the mechanisms behind how the gut microbiota provides
colonization resistance against C. difficile.
One of the many essential functions of the indigenous gut microbiota is its ability to maintain colonization
resistance and to prevent establishment and growth of pathogens in the gut. There has been a great deal of
research in this area trying to define the mechanisms by which the gut microbiota mediates colonization
resistance. Potential mechanisms include competition for nutrients, taking up physical space or biomass,
production of inhibitory products, and shaping the host immune response. A popular model organism used to
interrogate these mechanisms is Clostridioides difficile due to its exquisite sensitivity to changes in the gut
microbiota structure and function. C. difficile is an anaerobic, spore-forming, Gram-positive bacterium first
isolated in 1935 and the causative agent for C. difficile infection (CDI). Unlocking how C. difficile is able to
benefit from the loss of colonization resistance in the gut has major implications for development of
therapeutics for prevention and treatment of CDI.
My long-term goal is to understand how the gut microbiota mediates colonization resistance against C. difficile.
The overall objective of this application is to determine the relationship between nutrient availability (amino
acids) and bile acid metabolism in the context of colonization resistance against C. difficile. Based on
preliminary data our hypothesis is that amino acid availability influences secondary bile acid production by
commensal Clostridia, which will alter colonization resistance against C. difficile. In order to investigate this
hypothesis, we plan to alter amino acid abundances in defined and rich media in vitro, and use defined diets in
vivo to understand how this impacts secondary bile acid production of commensal Clostridia. Leveraging our
robust and reproducible germfree and antibiotic treated mouse models of CDI, we will determine how these
metabolic processes affect the establishment and growth of C. difficile, as well as the surrounding gut microbial
community. Using novel platforms like LC-IMS-MS and Protein-SIP, we will define the gut metabolome and
metaproteome in the context of colonization resistance.
The contribution of the proposed research is significant as it seeks to move away from untargeted therapies
like FMT and move toward a targeted approach, whereby we can use diet (amino acids) to control secondary
bile acid production by commensal Clostridia, restoring colonization resistance against C. difficile. The findings
in this proposal will advance understanding of microbe-microbe interactions, host-microbe interactions, and
improve microbiome-based therapeutics. Beyond C. difficile it has the potential to allow us to intelligently
design customized therapeutic interventions to target human health conditions in the complex ecological
environment of the human intestine.

Public health relevance
Project Narrative The proposed research is relevant to public health because determining how C. difficile is able to benefit from the loss of colonization resistance in the gut has major implications for the development of microbiome based therapeutics for prevention and treatment of CDI and many other GI diseases. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to developing fundamental knowledge that will reduce the burdens of human illness. The research is also relevant to the part of the NIGMS’s mission that pertains to supporting basic research, which increases the understanding of biological processes and lays the foundation for advances in disease diagnosis, treatment and prevention. The contribution of the proposed research is significant because it will define the dynamic relationship between nutrient availability and bile acid metabolism at the level of the individual microbial species in commensal Clostridia and within a microbial community. This proposal seeks to define their individual and combinatorial roles in how the gut microbiota is able to provide colonization resistance.